Health care factors affecting outcomes of vulnerable populations with SLE

Prior work by the investigators and others has shown that there are substantial differences in the health care received and in outcomes of SLE by race/ethnicity and socioeconomic status. The proposed project assesses the mediating impact of three sets of variables which together constitute

Public health relevance
Health care disparities among persons with SLE have long been noted, but relatively little progress in reducing such disparities has been made. The proposed project analyzes the role that three aspects of health care, access to timely and appropriate providers, technical quality of care, and interpersonal processes of care play in giving rise to differences in outcome by race/ethnicity and socioeconomic status and may help in the design of policies to reduce such differences.